DEVELOPMENT OF INSTRUMENTATION FOR MULTIPHOTON MICROSCOPY

Fluorescence correlation spectroscopy is ideally suited for detection and analysis of single fluorescent molecules, as exemplified by time traces of fluorescence bursts of individual rhodamine B molecules diffusing through the excitation volume. FCS using two-photon excitation provides the advantage of a mathematically well-defined three-dimensional geometry of the focal volume. During each event of a single molecule diffusing through the excitation volume, the burst of fluorescence can be analyzed in respect to fast kinetic processes with high statistical accuracy. We investigated single OD-TMR molecules in cell membranes by FCS and burst analysis with a multichannel scalar.